CHILDREN'S ANTIBODIES TO POLYSACCHARIDES--V REGION GENES

This study assesses the maturation of the serum antibody response of children and Adults to polysaccharide antigens. Serial serum samples from children and various ages will be assayed for antipolysaccharide antibody with respect to IgG subclass distribution and clonal diversity. Throat cultures are obtained to evaluate antigen (pneumococcus, group A beta strep) exposure.